Effects of lipidomic diversity on GPCR

Integral membrane protein (IMP) function depends on the membrane environment, both through the activity of specific lipids as allosteric modulators and via bulk membrane properties like viscosity, rigidity, and order. Recent lipidomic analyses have established the compositional details of membrane complexity, and provided clear evidence that disparate cell types — and even the same cell type in different individuals — present unique, grossly different membrane environments. Our preliminary observations suggest that these distinct membrane environments influence the conformation and activity of G protein-coupled receptors (GPCRs), and likely modulate their response to targeted therapeutics. Moreover, our recent observations reveal that membrane phenotypes are remarkably susceptible to exogenous perturbations, suggesting that extrinsic factors like diet or lipid synthesis inhibitors could synergize with GPCR-targeted therapeutics. It is therefore critical to define the spectrum of regulatory mechanisms imparted on proteins by lipid bilayers, with this knowledge especially impactful for high value targets, such as GPCRs. Our long-term goal is to exploit tissue-specific differences in membrane environments to predict and tune the efficacy and specificity of therapeutics targeting GPCRs. The objective of this proposal is to leverage advances in lipidomics and GPCR reconstitution to bridge the membrane complexity of live cells with the controlled environments provided by model systems. By combining genetics, cell biology, lipidomics, GPCR reconstitution into proteoliposomes, and molecular simulations we aim to determine the mechanisms by which membrane composition determines ligand binding and signaling characteristics for the adenosine A2A receptor (A2AR). Our central hypothesis is that ligand off-rates and G protein coupling are affected by local membrane order, which is a function of both cholesterol concentration and overall lipid composition. Across model systems, our preliminary observations suggest that cholesterol concentration is a key modulator of GPCR activity, with effects on both ligand binding thermodynamics and signaling kinetics. We will decipher whether the effects of cholesterol are due to specific interactions with the receptor or effects on membrane physical properties by independently varying and measuring these properties in simulations, model membranes, and live cells. Lipidomic analysis of A2AR-relevant target cell types — neurons, leukocytes, cardiomyocytes, and epithelial cells — will inform molecular simulations of complex mixtures, and reconstitution of A2AR into membranes obtained from these same cells will determine the extent of signaling variation across cell types. Finally, we will test whether the effects of lipidomic perturbations — including cholesterol depletion / loading, fatty acid feeding, and drugs that modulate fatty acid and cholesterol synthesis — recapitulate A2AR functional dependence observed in model systems. This final goal will test a prototype therapy based on lipidomic perturbation, to locally and specifically enhance A2AR therapeutics..

Public health relevance
More than half of all pharmaceuticals act via targets in the exterior membrane of the cell. Variations in membrane composition, which arise due to differences in cell type, as a result of drugs such as statins, and due to differences in diet, are known to impact membrane protein function, and therefore will also impact the action of pharmaceuticals targeting these proteins. For example, the A2A adenosine receptor is a target both for Parkinson’s therapies in neuronal cells, and for imaging blood flow in the heart — two kinds of cell with very different membranes. The goal of this proposal is to determine the extent to which variations in membrane composition might be exploited to develop more specific, efficacious, and personalized medicine, using A2A as a test case.